A self-assembled hydrogel with tunable drug release kinetics for preventing osteoarthritis in active joints

Sustained intra-articular delivery of disease modifying osteoarthritis drugs (DMOADs) holds promise for preventing
the progression of osteoarthritis (OA). However, since (DMOADs) are intended for early OA, when patients are
active, repeated mechanical loading of joints can be detrimental to the delivery system, causing rapid drug
release. To our knowledge, none of the previously reported intra-articular platforms for DMOAD delivery have
been evaluated in physically active animals or have considered the impact of activity induced mechanical
stress on the delivery platform and the drug release. We have developed a hydrogel platform that can rapidly
recover following mechanical stress relevant to running human knee joints, with no impact on sustained
release of the encapsulated agents. Hydrogel loaded with cathepsin-K inhibitor (L-006235) – a small molecule
DMOAD prevented OA progression in mice undergoing treadmill running. The overall objective of this
application are to (i) develop variants of our hydrogel platform with different release kinetics of L-006235 to
understand how local release kinetics/pharmacokinetics impacts therapeutic efficacy and (ii) further engineer
the hydrogel platform for delivery of biologic DMOADs. Our long-term goal is to develop a versatile and
mechanically stable drug delivery platform with tunable release kinetics for intra-articular delivery of DMOADs
in active joints to prevent OA progression. Our central hypothesis is that a mechanically stable hydrogel
platform can minimize the impact of joint-related mechanical stress on sustained release of DMOADs and
therapeutic efficacy of this system can be maximized by tuning the local release kinetics of DMOADs. To
achieve our objectives, we propose two specific aims: 1) Investigate the impact of release kinetics of L-006235
on therapeutic efficacy; and 2) Investigate the delivery of biologic DMOADs in active joints using hydrogel.
Under the first aim, we will develop hydrogel variants with different release kinetics of L-006235 and will study
the impact of mechanical stress relevant to human joints on hydrogel variants and L-006235 release. Next, we
will validate the differences in release kinetics in treadmill running mice and evaluate the therapeutic efficacy
and off-target effects in treadmill running mice with OA. For the second aim, we will identify formulation
parameters, including TG-18 concentration and choice of solvent to maximize loading and stability of three
different biologic DMOADs (IL-1Ra, FGF-18 and sTNFRII). Formulations will be evaluated for mechanical
stability in vitro, release kinetics in treadmill running mice and efficacy and off-target effects in treadmill running
mice with OA. The research proposed in this application is innovative, in our opinion, because it focuses on a
novel hydrogel platform that is mechanically stable in joints, allows tunability of release kinetics and is
versatile. We will be the first to (i) demonstrate therapeutic efficacy of a wide range of DMOADs in “physically
active joints” and (ii) demonstrate that release kinetics of DMOADs defines their therapeutic efficacy. The
proposed research is significant because it is expected to provide strong scientific justification for continued
development and future clinical trials of this promising hydrogel that will enable us and others to compare the
effect of different DMOADs on OA pathology in active joints, and identify the most promising DMOADs and
their ideal release kinetics. Ultimately, such knowledge has the potential to offer paradigm shifting impact in OA
therapy by enabling translation of promising DMOADs.

Public health relevance
The proposed research is relevant to public health because it focuses on developing a new drug delivery strategy to enable clinical translation of therapeutics that can prevent the progression of early osteoarthritis (OA). Once this platform is developed, there is a potential for a paradigm-shifting impact in OA therapy for active patients with early disease. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to reducing the illness and disability.